Task C3: Testing an insecticidal agent against mosquitos harboring arboviruses (Zika fever)

This contract provides in vitro testing of potential agents to treat parasites and their vectors, maintenance of parasite and vector stocks, and the development of related assays.